READING THE NEURAL CODE IN THE MAMMALIAN VISUAL SYSTEM

A major challenge in studying sensory processing is to understand the meanings of the neural messages encrypted in the spiking activity of neurons. The ability to "read the neural code" is essential for our understanding of the neural mechanisms underlying brain functions. The proposed project aims to understand the neural code in the early visual pathway, i.e., the lateral geniculate nucleus (LGN) and the primary visual cortex. We will use a combination of experimental and computational approaches to address this problem from two directions. In the forward direction, we will use a computational method to characterize more systematically features of visual inputs that are encoded in neuronal responses. In the reverse direction, we will reconstruct visual inputs from the recorded neuronal activity. In part 1, we will use decoding techniques to reconstruct spatiotemporal natural scenes from ensemble responses in the LGN. In part 1, we will use decoding techniques to reconstruct spatiotemporal natural scenes from ensemble response in the LGN. The optimal linear decoding technique, which has been used successfully in a preliminary study, will be applied to further explore the functions of precisely correlated spiking in the LGN in visual coding. We will also explore the use of a gradient descent learning algorithm to train artificial neural networks to perform optimal input reconstruction. In part 2, we will use a covariance matrix analysis to systematically characterize the features of visual inputs that are represented by the responses of primary visual cortical neurons. Since most of the cortical neurons are complex cells with highly non-linear responses, a complete description of their coding properties is difficult to obtain with conventional methods. The covariance matrix analysis may help to reveal previously unknown coding properties and may provide new insights into the nature of the neural code in the primary visual cortex. Finally, in part 3, we will apply decoding techniques to reconstruct natural scenes using properties identified by both conventional techniques and by the covariance matrix analysis. This will provide a critical test of our computational model of cortical visual coding developed in part 2. The large amount of information on the anatomy and physiology of the early visual pathway makes it an idea model for computational analysis for neural coding. The results from the proposed studies are likely to provide new insights into the general principles of sensory coding and may advance our understanding of the neuronal mechanisms of higher brain functions under normal and pathological conditions.